Scientific Information Management and Literature-Based Evaluations for the DTT - Support for Scoping & Systematic Review Activities on PAHs and Nitro-PAHs

The Division of Translational Toxicology performs scoping and systematic reviews of literature to assess the potential for adverse effects on human health by agents, substances, mixtures, or exposure scenarios, based on information about human exposure. The findings of these reviews are generally focused on either cancer or non-cancer effects and published as monographs or manuscripts. The systematic reviews on polycyclic aromatic hydrocarbons (PAHs) and nitro-PAHs are being conducted in support of the congressionally mandated Report on Carcinogens (RoC). The RoC lists substances that pose a cancer hazard for people living in the United States, and also documents information related to the cancer hazard evaluation of substances as potential new listings in the report. The scoping review of PAHs is being conducted as a related evaluation of non-cancer health effects. Keywords: systematic review, toxicology, epidemiology, exposure, cancer effects, non-cancer effects.